Impact of Veteran Voices & Visions Peer Support Groups on Social Integration for Veterans with SMI/Psychosis

Veterans with Serious Mental Illness (SMI) struggle with social integration - participation in work, housing, and
citizenship - due to symptoms, stigma, and psychosocial functioning deficits. This has a tremendous impact on
mortality, comparable to that of smoking and greater than obesity and alcohol abuse. Despite considerable VA
efforts to provide mental health care to Veterans with SMI, programs that promote social integration are
lacking. Veterans with SMI are at especially high risk for poor social integration and suicidal ideation during the
COVID-19 pandemic. There is an urgency to advance treatments targeting Veterans' social integration.
This project addresses this need with a group-based, peer specialist (PS) co-facilitated psychosocial
intervention for Veterans with SMI, called “Veteran Voices and Visions” (VVV). VVV targets Veterans with SMI
who experience psychosis, a group particularly in need of support with social integration. Virtual VVV groups
are co-led by VA mental health clinicians (MHCs) and PSs via online video conference. VVV is an adaptation
of a community-based support group model called the Hearing Voices (HV) approach that was developed over
30 years ago in the Netherlands. It has since spread to over twenty-five countries, representing hundreds of
support groups worldwide. The approach facilitates group cohesion around and normalization of the common
psychotic symptoms of SMI: hallucinations, delusions, and social isolation. Despite its global scope, this
approach has neither been formally adapted nor rigorously studied in public health systems, including the VA.
This intervention has the potential to create and foster a supportive community that improves the social
integration of participants by reducing their distress and self-stigma, and increasing self-efficacy. These three
process outcomes are strongly associated with social integration. This proposal is directly aligned with VA
priorities to advance the breadth of existing psychosocial interventions for Veterans with SMI, improve access
via telehealth services, and support Veterans' independence, wellbeing, empowerment, and whole health.
The goal of this proposal is (1) to develop a manual, training guidelines, and a fidelity scale for VVV, (2) to
assess the feasibility and acceptability of VVV, and (3) collect pilot outcome data. The manual, training
guidelines, and fidelity scale will be developed by the research team in collaboration with 4 advisory panels:
Veterans with SMI, MHCs, PSs, and non-VA experts in HV. Then, 5 MHCs and 5 PSs will be trained to use the
new VVV manual, and each MHC-PS pair will conduct a group with the new protocol. Thirty Veterans will be
recruited to participate in these 5 groups and assessments will be conducted at baseline, midpoint, and post-
intervention. Baseline assessments include measurement of psychiatric symptoms, level of distress from
psychosis, internalized self-stigma, self-efficacy, sense of belonging, recovery, and social integration. Follow-
up assessments conducted at 10 and at 20 weeks will include these same measurements as baseline, as well
as a survey and qualitative interview on intervention acceptability. Feasibility data on numbers approached,
enrolled, and retained, and treatment fidelity will be collected. Fidelity will be assessed in two ways: (1)
facilitators will complete self-administered reflection worksheets after each session and (2) research team
members will rate 5 randomly selected audio-recorded sessions from each group for formal fidelity ratings.
The goal of the within-subjects trial evaluating feasibility and acceptability of the manualized VVV protocol for
improving self-efficacy, self-stigma and social functioning in Veterans with psychosis. To that end, the study
will be run using the full collection of measures that would be included in a subsequent RCT. However, since
the study is designed to assess whether the proposed intervention can be successfully implemented in the
target population and to evaluate the properties of a candidate set of outcome measures, rather than
demonstrate efficacy, most of the analyses will be descriptive. This will lay the groundwork for a future Merit
that will support a controlled efficacy study.

Public health relevance
Veterans with Serious Mental Illness (SMI) struggle with social integration - participation in work, housing, and citizenship - due to symptoms, stigma, and psychosocial functioning deficits. This has a tremendous impact on mortality, comparable to that of smoking and greater than obesity and alcohol abuse. While the VA has made considerable efforts to provide mental health care to Veterans with SMI, programs that promote social integration are lacking. This project targets an especially vulnerable group, Veterans with SMI experiencing psychosis, with a peer support-based group approach. This virtual innovation is based on efforts from a consumer-driven, global social movement called the Hearing Voices approach. We seek to adapt and standardize this approach within the VA context via the development of a manual, training program for VA mental health clinicians and peers, and fidelity scale, which will then be piloted with 30 Veterans in 5 groups of 6 Veterans over the course of 20 weeks. This information will support the design of a controlled efficacy study.